Inflammatory and Fibrotic Responses to Malondialdehyde-Acetaldehyde Adducts in Rheumatoid Arthritis

With an aging population and epidemiologic risk factors that include cigarette smoking and military burn pit
exposures, the burden posed by rheumatoid arthritis (RA) and fibrotic RA-associated interstitial lung disease
(RA-ILD) will grow dramatically among U.S. veterans in coming years. Despite the availability of advanced
therapies, up to half of RA patients do not achieve adequate disease control, contributing to increased morbidity
and mortality. No current therapies in RA simultaneously target the inflammation and fibrosis that characterize
RA or RA-ILD. A long-term goal of our research team is to identify novel treatment targets in RA by defining the
pathogenic role that post-translationally modified proteins (PTMs; citrulline [CIT] or malondialdehyde-
acetaldehyde [MAA]) play in RA pathogenesis. Previously, our group demonstrated that MAA-modified proteins
are abundant in RA synovium and in lung tissues where they strongly co-localize with CIT. We have generated
robust preliminary data demonstrating that dually-modified proteins (CIT+MAA) result in macrophage (MΦ)
activation that uniquely yields both pro-inflammatory and pro-fibrotic effects. CIT+MAA-induced activation leads
to increased expression and function of calcium (Ca++) dependent peptidyl-arginine deiminase (PAD), furthering
protein citrullination, and producing soluble mediators that crosstalk with human fibroblasts to produce
extracellular matrix (ECM). Therefore, our overarching hypothesis is that co-modified protein leads to a
mixed M1-like (pro-inflammatory) and M2-like (pro-fibrotic) MΦ phenotype that promotes tissue
inflammation and fibrosis via the production of both citrullinated and non-citrullinated mediators. To
investigate this hypothesis, studies in Aim 1 will identify mechanisms by which MAA-modified and/or CIT proteins
activate human MΦs leading to increased PAD expression and function. In Aim 2, we will identify soluble
mediators secreted by MΦs in response to stimulation with CIT±MAA-modified proteins that promote fibroblast
function and ECM deposition. This will include translational studies to examine the relationship of a soluble
mediator already identified in preliminary work (platelet-derived growth factor [PDGF]-BB) with the development
of incident RA-ILD using a uniquely available longitudinal cohort of U.S. veterans with RA. In Aim 3, we will
leverage a novel murine model of RA-ILD that combines collagen-induced arthritis (CIA) and lung injury to
quantify the anti-inflammatory and anti-fibrotic efficacy of targeted inhibitors of CIT/MAA formation and PDGF-
BB signaling. At the completion of this research, we anticipate having a precise understanding of how CIT and
MAA-modified proteins together (and in isolation) facilitate RA and RA-ILD progression through MΦ activation,
MΦ-fibroblast crosstalk, inflammation and fibrosis. Results will include the identification of targetable pathways
that will ultimately open new avenues of translational research and yield novel therapeutic approaches in RA.

Public health relevance
Over the last two decades, the prevalence of rheumatoid arthritis (RA) in the VA has increased by more than 60%, highly relevant since male veterans with RA experience more than twice the mortality as age-matched men from the general population. Our group has shown that proteins in RA are naturally modified as a product of oxidative stress by malondialdehyde-acetaldehyde (MAA). This change enhances both inflammation and fibrosis in disease states such as RA. Proposed research efforts will focus on identifying the biologic mechanisms linking MAA-adduct formation to the development and progression of RA and RA-associated lung disease. Importantly, results from this work will lead to an improved understanding of the events leading to RA development and will provide insight into new approaches of treatment and prevention.